ALPHA INTERFERON WITH DDI IN TREATMENT OF KAPOSI'S SARCOMA

A randomized phase II trial to determine the safety, tolerance and efficacy of two doses of interferon alpha combined with didanosine in patients with Kaposi's sarcoma.